The Stanford Clinical Center for the Study of Chronic Pancreatitis, Diabetes, and Pancreatic Cancer

Project Summary/Abstract
This application is for an administrative supplement to support our participation in the Consortium for
the Study of Chronic Pancreatitis, Diabetes and Pancreas Cancer (CPDPC). It will specifically enable
the Stanford Clinical Center to continue its productive recruitment of patients into 3 key clinical studies
of the consortium – 1) Prospective Evaluation of Chronic Pancreatitis for Epidemiologic and
Translational Studies (PROCEED), 2) Pediatric Longitudinal Cohort Study of Chronic Pancreatitis
[The International Study Group of Pediatric Pancreatitis: In Search for a Cure (INSPPIRE2), and 3)
Evaluation of a mixed meal test for Diagnosis and characterization of Pancreaticogenic Diabetes
secondary to pancreatic cancer and chronic pancreatitis (DETECT). These funds will support patient
related costs in enrollment and fulfilling protocol-defined tasks including the collection and processing
of biospecimens for each protocol.

Public health relevance
PROJECT NARRATIVE The Stanford Clinical Center will continue to lead and actively participate in the research objectives of the Chronic Pancreatitis, Diabetes, and Pancreas Cancer (CPDPC) Consortium by recruiting into the 3 key clinical studies. This administrative supplement will support the collection of bio-specimens from these studies per protocol. The results of these studies will provide insights that will inform new diagnostic tests and treatments.